Genetic determinants of inter-individual variation in the dynamic transcriptional innate immune response to Mycobacterium tuberculosis

PROJECT SUMMARY
Infectious diseases are a major public health burden throughout the world. Tuberculosis (TB), caused by the
pathogen Mycobacterium tuberculosis (Mtb), is estimated to kill nearly 2 million individuals worldwide every year
alone. Notably, humans show remarkable differences in susceptibility to many pathogens, including Mtb.
Arguably, this heterogeneity arises from variation in the immune response, which is responsible for preventing
and controlling infection. Although a significant proportion of inter-individual variation in susceptibility to Mtb
infection can be attributed to environmental factors, a substantial portion is due to host genetic factors. The
importance of host genetic factors in susceptibility to clinical TB has been demonstrated by twin and family
studies. However, the underlying genetic factors that drive inter-individual differences in susceptibility to Mtb
infection remain largely unknown, especially at the population level. Using combined expertise in functional
genomics, computational biology, human immunology, and population genetics, I propose to: (i)
characterize the
inter-individual and inter-population transcriptional variation in the innate immune response to Mtb infection; (ii)
map expression quantitative trait loci (eQTLs) that are associated with variation in the response to Mtb infection ;
and (iii) determine the role of recent positive selection in shaping ancestry-associated differences in gene
expression. This work will yield unprecedented insight into the genetic determinants underlying inter-individual
and population-associated variation in the transcriptional innate immune response to Mtb infection. Further,
these efforts will establish innovative, novel, and empirically-grounded transcriptional profiling strategies to
pinpoint highly-promising genetic candidates for Mtb susceptibility, which will allow us to identify the individuals
who are at increased risk for TB, one of the greatest health burdens facing modern human populations.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB), which is caused by the pathogen Mycobacterium tuberculosis (Mtb), is a significant worldwide public health burden. Across individuals and populations, differences in susceptibility to TB have been described; however, the factors that underlie this variation are not well characterized. This project will use innovative molecular and statistical approaches to identify the genetic determinants that contribute to inter-individual and ancestry-associated variation in the innate immune response to Mtb infection.